CTSA K12 Program at Virginia Commonwealth University

The COVID-19 pandemic highlighted the critical importance of translational research to eradicate human
disease, tackle emerging public health threats and promote health, especially in hard-to-reach communities that
face health disparities. To take on these challenges, we need a diverse, well-resourced, and well-trained
research workforce, as highlighted by the NIH Physician-Scientist Workforce report. 1 The VCU Wright Regional
Center for Clinical and Translational Science (Wright Regional CCTS) serves a region in Central and Eastern
Virginia and North Carolina that includes both rural and urban underserved communities and has vast experience
serving a diverse community of patients who often face health disparities. The nature of our environment has
driven the development of a research workforce that is prepared to meet the challenge of engaging and serving
diverse patients. The Wright Regional CCTS serves as the hub for providing the translational research
infrastructure for the training and career development of scholars through their professional life cycle. In addition,
The Wright Center CCTS has a $32 million endowment with which we have established the first Wright Faculty
Scholars in Health Disparities program. This program supports early career faculty from diverse backgrounds
who are committed to better understanding the drivers and developing solutions to health inequities in our
communities. Our existing partner institutions bring experience training the workforce across the translational
spectrum with an emphasis on community engaged research (Eastern Virginia Medical School (EVMS)),
informatics (Old Dominion University (ODU)) and mentorship (Virginia State University (VSU), an HBCU).
Training scholars to translate research observations to clinical application in our unique
communities is a priority for the proposed K12 Training Program. Our program will continue its commitment
to providing early career faculty/late-stage postdoctoral fellows with a comprehensive “blueprint” for transitioning
to research independence. We will recruit scholars from a pool of early career scientists who are diverse in both
research discipline and demographics. Through integration with our UM1 and RC2 awards, K12 scholars will
be exposed to an innovative and comprehensive program that supports 75% committed time to scholar
specific domain expertise but also provides a combination of didactic, virtual, and experiential training in
fundamental characteristics of the translational scientist.
We will achieve our goals through the following specific aims:
Aim 1: Prepare early career translational researchers for research independence through comprehensive,
innovative, and individualized training in translational science. K12 scholars will be positioned to translate
preclinical, clinical, and community-based research to improving health of all communities.
Aim 2: Serve as an institutional resource for research career development and facilitate the creation of a diverse
community of clinical and translational researchers through both internal and external partnerships.

Public health relevance
This K12 training program from partner institutions at the Wright Regional Center for Clinical and Translational Research will train scholars to translate research observations to clinical application in our unique communities. Our program will continue its commitment to providing early career faculty/late-stage postdoctoral fellows with a comprehensive “blueprint” for transitioning to research independence. We will further leverage our bidirectional partnerships with local institutions (EVMS, ODU, and VSU), further synergize with internal programs (UM1, T32 and RC2) and Center on Health Disparities pipeline training grants to promote the development of a diverse research workforce (K12, T32, R25), and to further build a community of scholarship while fostering the development of a pipeline beyond our K12 scholars.